A new drug to treat transplant-associated renal ischemia-reperfusion injury

PROJECT SUMMARY/ABSTRACT
Renal replacement therapy is a worldwide problem. Kidney transplantation (KTx) provides significant
advantages over dialysis in terms of health outcomes and quality of life. However, there is a shortage of organs
given this growing population. Centers have lowered standards for acceptable transplant organs. Thus,
transplantation (Tx) of kidneys that have undergone longer periods of ischemia or are from older or deceased
donors is on the rise. Due to the extended hypoxia endured by these “less ideal” organs, ischemia-reperfusion
injury (IRI) results upon Tx. IRI is caused by complex oxidative and inflammatory assaults on damaged ischemic
cells following the reintroduction of blood flow after a period of oxygen deprivation. Tissue becomes swollen due
to inflammation and vascular leakage. Microvascular thrombosis causes vascular occlusion, depriving blood
supply to tissues in the newly transplanted organ. IRI leads to cell death and renal impairment, including delayed
graft function (DGF) and rejection. There is a need for a therapy that reduces inflammation and thrombosis,
without increasing vascular leakage and postoperative bleeding. Most drugs with potential to treat IRI induce
bleeding and should not be taken in conjunction with surgery. Our overall objective is to develop a new drug
for treatment of IRI associated with organ Tx, which potently inhibits both thrombosis and inflammation
without causing vascular leakage and bleeding. Based on our new concept (Gong et al. Science 2010, Shen
et al, Nature 2013) that Gα13-dependent outside-in signaling of the platelet integrin αIIbβ3 (GPIIb-IIIa) is
selectively important in occlusive thrombosis but not hemostasis, we designed a peptide inhibitor of the Gα13-
integrin interaction, M3mP6, and a novel high-loading peptide nanoparticle (HLPN) formulation for in vivo
intracellular peptide delivery. In proof-of-concept studies, we have demonstrated that M3mP6 HLPN potently
inhibits renal IRI caused by a pedicle clamping without causing bleeding. Importantly, M3mP6 also has anti-
inflammatory effects mediated by inhibition of β2-Gα13 binding in leukocytes, thereby reducing neutrophil
function. Pilot toxicology studies carried out with M3mP6 HLPN showed no toxicity. Based on these exciting new
data, we propose in this Phase I SBIR application to further develop this novel drug from the proof-of-concept
stage to IND for the treatment of renal IRI associated with KTx. Our specific aims are (1) Evaluate the effect of
M3mP6 HLPN on KIRI-associated renal thrombosis, inflammation, and vascular leakage. (2) Characterize
therapeutic efficacy of M3mP6 HLPN in an KTx IRI mouse model. (3) Scale-up method development for M3mP6
HLPN formulation. If successful, this new drug should have a major impact in further improving outcomes
following renal IRI associated with KTx.

Public health relevance
PROJECT NARRATIVE Kidney transplantation has shown great success in terms of improving health outcomes and quality of life. However, a shortage in donor kidneys has resulted in transplant of unideal organs causing a problem known as ischemia reperfusion injury. This injury occurs when the kidney is deprived of oxygen for an extended period. An inflammatory storm occurs when the organ is reconnected to blood flow, causing renal damage and dysfunction, of then resulting in kidney failure. Current treatments have limited effectiveness due to bleeding side effects and lack of anti-inflammatory properties. We have invented a new drug that blocks both thrombosis and inflammation without causing bleeding and demonstrated its efficacy in treating renal ischemia-reperfusion injury in a mouse model. In this application, we propose to further test the efficacy and safety of this new drug and develop it for the clinical treatment of ischemia-reperfusion injury associated with kidney transplantation.